Tufts BIRCWH Program

Enter the text here that is the new abstract information for your application. This section must be no longer than 30 lines of text.
TUFTS BIRCWH -- K12AR084217
Revisions June 2, 2025
Project Summary:
There is a demonstrated need to increase the number of exceptional researchers in women's health and sex differences to better understand basic mechanisms of disease and develop treatment that addresses the heterogeneity of treatment effects by sex. The Tufts University Building Interdisciplinary Research Careers in Women's Health (BIRCWH) Scholars Program proposes the continuation of a model program to recruit, select, and train early career faculty to conduct basic research in sex differences and clinical and health services research on women's health issues. The long-term goals of the Tufts BIRCWH Program are to develop the next generation of leaders in research in sex differences and women’s health. The Program will fund faculty within six years of their training. We will fund two types of trainees, Basic Science Scholars and Clinical Scholars, who have completed their doctoral training but require more in depth interdisciplinary research training. The Program will achieve its goals through five key activities, tailored to meet each Scholar’s training needs: 1) interdisciplinary mentoring teams, 2) formal research training including courses at the Graduate School of Biomedical Sciences, 3) interdisciplinary research seminars, 4) a mentored research project, and 5) development of skills in grant proposal preparation. The Tufts BIRCWH Program will promote all stages of research from basic science in sex differences to clinical and outcomes research focusing on several important questions in the care of women: a) discovery of sex differences, b) disease prevention, management, and outcomes, c) nutrition science, d) women’s cardiovascular health, and e) maternal health and impact on the life course. We propose to fund three scholars annually, with initial appointments of two years with an option to be considered for a third year.

Public health relevance
There is an urgent need to train investigators with an understanding of how to conduct research to understand the sex differences in basic disease mechanisms and to understand the heterogeneity of treatment effects by sex in devices, drugs, and other treatments. By harnessing the incredible talent and leveraging the unique resources of the Tufts community, Dr. Freund and Dr. Jaffe have developed and further expanded the Tufts University BIRCWH Scholars Program. This tailored training program for Early Career Investigators focuses on sex differences and women's health research and ensures the training of a cadre of investigators to become the future research leaders in this critical area.